Maternal exposure to chemicals and offspring neurodevelopmental disabilities: informing public health actions by understanding nutritional modifiers and simulating interventions

PROJECT SUMMARY (See instructions):
Humans are ubiquitously exposed to metals and per-and polyfluoroalkyl substances (PFAS), which are either established or suspected
neurotoxicants in experimental and population settings. Exposure to these chemicals can be particularly harmful in utero, a critical period of fetal
brain development. Four major literature gaps exist: 1) prospective studies of in utero exposure to these chemicals and child risk of
neurodevelopmental disorders (NDs) are limited in the U.S, with most studies from predominantly White, European populations; 2) despite
growing evidence that these chemicals may affect multiple NDs and systems, most studies are limited to a single ND outcome without
consideration of comorbidities; 3) exposures rarely occur in isolation, yet combined exposure across different chemical classes remain unclear
let alone chemical-nutrition interplay (nutrition may modify chemical toxicities); 4) most children’s environmental health studies focus on
identifying risk factors with few that use or develop solution-oriented analytic methods that can directly inform public health actions. To fill these
critical gaps, Dr. Choi proposes to investigate nutritional modifiers that may mitigate relationships between chemicals (i.e., metals and PFAS)
and NDs and generating policy-relevant effect estimates via simulating intervention effects on chemicals and nutrition. To address this
overarching goal, she will leverage rich existing resources (biospecimen data and clinical diagnoses of NDs and comorbidities across the
lifespan) in the Boston Birth Cohort, a large prospective birth cohort with a significant representation of understudied low-income minorities. In
R00, Dr. Choi will utilize the newly assayed PFAS data on which she has conducted quality control assessments during the K99 to complete
Aims 1-2. For the adverse chemical-ND relations identified in during the K99 phase, she will evaluate nutritional modifiers (Aim 1) and simulate
intervention effects by estimating the number of NDs that could have been prevented had there been pregnancy interventions on chemicals,
nutrition, and both chemicals and nutrition (Aim 2). This R00 will position Dr. Choi as an innovative, independent researcher in environmental
epidemiology, with a unique niche in NDs and comorbidities, chemical-nutrition interplay, research translation, and advanced methods. Our
findings and activities will increase public awareness and serve as scientific evidence for future policies on the environment or nutrition to reduce
the burdens of NDs.

Public health relevance
RELEVANCE (See instructions): Metals and PFAS are neurotoxic, however, nutritional modifiers of their effects on neurodevelopmental disorder diagnoses remain unclear let alone how to minimize chemical toxicities on human health. This study will investigate the roles of nutritional modifiers of chemicals - neurodevelopmental disorders relationship, and predict the effects of hypothetical interventions to reduce chemical neurotoxicity. Our findings will inform interventions and policies to promote children’s mental health and well-being.